INSULIN SECRETION PULSATILITY IN MAN

This study will evaluate details of the relationship between pulsations in plasma glucose and those of plasma insulin. Also investigated are whether the pulsations in glasma glucose are reflected and/or caused by fluctuations of glucose uptake in peripheral tissues.